EFFECTS OF GLUCOSE, LIPID, AND AMINO ACIDS ON PROTEIN METABOLISM IN NEWBORNS

The purpose of this protocol is to examine the extent to which intravenous amino acid, glucose or lipid result in the suppression of proteolysis, stimulation of protein synthesis, or a reduction of protein oxidation in the newborn in order to more optimally provide parenteral nutrition to newborns.